Pubovisceral muscle enthesis injury: A bioinspired approach to repair

PROJECT SUMMARY
Each year, at least 20% of women who give birth vaginally sustain an avulsion of the pubovisceral muscle
enthesis (PVME) at the pubic bone, substantially predisposing to pelvic organ prolapse (POP) and associated
disorders later in life. POP, a chronic disease unique to women, represents a major public health burden since
12.6% of US women will undergo a major surgical repair of POP by age 80, at an estimated cost of > $10 billion
annually. Currently, our inability to repair PVME avulsions, either at the time of injury or later in life when POP
has occurred, severely undermines the outcomes of current POP surgeries. PVME injuries are rarely recognized
at vaginal birth, and given that there is no viable treatment, there is little incentive to change this standard of
care. Lack of fundamental and longitudinal data on the pathophysiologic events that follow PVME avulsion and
the related biomechanical consequences further hinders the design of interventions. Bridging this knowledge
gap, the current proposal will first investigate the structure and function of native PVME and the pathophysiologic
events following injury, so as to inform the design of a composite scaffold that orchestrates an integrative repair.
We hypothesize that a surgically placed bioinspired composite scaffold with pre-engineered biomimetic
spatial cues in structure and composition will enable enthesis regeneration that will be superior to suture
repair. To test this, we develop a comprehensive framework for defining PVME injury and repair based on
transperineal ultrasound to 1) improve the identification of patients who will have persistent levator avulsion and
are candidates for repair; and 2) guide the development of design parameters for an effective repair using a
bioinspired graft. Statistical shape models derived from 3D MRI models will be used as a gold standard to inform
the diagnostic interpretation of corresponding shape models established from transperineal ultrasound (TPUS)
in women with and without PVME injury. These analyses will be further informed by finite element simulations
predicting functional deficits after PVME injury and subsequent parametric studies of enthesis repair to enable
the establishment of basic design criteria for a scaffold based repair. In parallel, we perform cell culture and small
animal studies (Aim 2) to investigate matrix attributes, cell populations, and molecular and mechanical cues
involved in enthesis repair to further refine scaffold design and define needs for durable repair. With its high
capacity for biomimicry, a nanofiber-based bilayer scaffold with a mineralized component for osteointegration
and a nonmineralized portion for tendon formation already established to regenerate a functional tendon-bone
interface in rotator cuff repair will be adapted for PVME. Fiber diameter, alignment, and mineral content will be
readily optimized in Aim 2 to guide the cell response and direct enthesis healing. Finally, a nonhuman primate
model will be employed in a preclinical study that compares scaffold to suture repair and uninjured enthesis (Aim
3). We firmly believe that development of this bioinspired composite scaffold for PVME repair will lead to a
paradigm shift in the treatment of traumatic childbirth to the benefit of women world-wide.

Public health relevance
PROJECT NARRATIVE Avulsion of the pubovisceral muscle from the pubic bone at vaginal birth is one of the primary mechanisms leading to the development of pelvic organ prolapse later in life; yet, this injury is largely ignored since there are currently no strategies for repair. Here we propose to define the pathological changes that follow avulsion and physiologic recovery to inform the design of novel and effective therapeutic solutions to the benefit of women world-wide.